pH-Dependent Switching of ESX-1 Substrates in Mycobacterial Pathogenesis

PROJECT SUMMARY
Pathogenic mycobacteria, including Mycobacterium tuberculosis, cause acute and chronic infections that significantly im-
pact human health. Mycobacterium marinum is a non-tubercular mycobacterial pathogen and a well-established model for
studying several aspects of M. tuberculosis pathogenesis, including ESX-1 secretion. Early during infection, pathogenic
mycobacteria reside in and adapt to the phagosome. The pH of mycobacterial phagosomes differs based on the immunolog-
ical activation state of macrophages. Although mycobacteria escape the phagosome using the ESX-1 secretion system, the
mechanisms used by ESX-1 to lyse phagosomes under conditions of varied pH is a major gap in our fundamental under-
standing of mycobacterial infections. The applicant’s preliminary data suggest that the ESX-1 system switches which sub-
strates are secreted in response to acidic pH. The long-term goal is to understand the molecular mechanisms of mycobacte-
rial pathogenesis. The objective of this proposal is to determine how ESX-1 secretion promotes lysis in response to varying
pH in vitro and during infection. The central hypothesis is that pathogenic mycobacteria switch the substrates secreted by
ESX-1 in response to acidic pH to lyse phagosomes in macrophages of different immunological activation states. The ra-
tionale for this project is that defining how mycobacteria respond to different host cell physiologies may offer critical insight
important for considering treatment and prevention of mycobacterial diseases. The central hypothesis will be tested by
following these specific aims: 1) Define the genetic requirements for hemolysis at acidic pH. Under the first aim, targeted
and unbiased molecular genetic approaches combined with qRT-PCR, IP followed by proteomics and ESX-1 functional
assays will be used to identify the genes and mechanisms underlying lytic activity at acidic pH. 2) Measure changes in ESX-
1 secretion in response to acidic pH. The second aim will use proteomics to measure changes to the secreted proteomes of
M. marinum and M. tuberculosis at acidic pH. 3) Investigate substrate switching during mycobacterial infection. The third
aim will combine molecular genetics, chemical inhibitors of acidification and immune-activated infection models, and ani-
mal models to determine if specific substrates are conditionally transcribed and required during M. marinum and M. tuber-
culosis infection. The research proposed research is conceptually innovative because it tests the idea that ESX-1 switches
substrates to lyse phagosomes associated with heterogeneous macrophage physiologies. The formation of multiple ESX-1
assemblies in response to environmental cues is conceptually innovative. There is technical innovation in the chemical
inhibition of ESX-1 lytic activity, through leveraging a unique and comprehensive M. marinum strain collection for use with
established proteomics work flows, and in the use of differentially activated cellular and animal models of infection. The
successful completion of this proposal will be significant because it will identify seminal ESX-dependent virulence mech-
anisms and provide new insight into mycobacterial infection biology by generating understanding of how mycobacteria
respond to heterogeneous host cells during infection.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on understanding the fundamental mechanisms underlying infection by mycobacterial pathogens, which could inform new approaches to prevention, diagnosis and treatment of tuberculosis. This research is relevant to NIH’s mission because improving prevention, diagnosis and treatment of tuberculosis would help alleviate the tuberculosis pandemic.